Training in Clinical Translational Science: Maximizing the Public Health Impact

Project Summary/Abstract
This unique program leverages two developments in medicine and clinical science to enhance the predoctoral
training of psychological and brain scientists to make breakthroughs in understanding, preventing, and treating
psychopathology. One development, the NIH initiative to foster clinical translational science (CTS), is motivated
by the unmet critical need to move clinically relevant scientific discoveries along the translational pipeline—from
basic science to controlled research with clinical populations to dissemination and implementation—to make a
substantive public mental-health impact. A second development, the NIMH Research Domain Criteria (RDoC)
initiative, is motivated by the critical need to develop multi-dimensional, multi-unit-of-analysis approaches to
understanding psychopathology. Advances in clinical psychological science will come from a new generation of
investigators with expertise at the intersection of these two NIH-driven developments. The goal of this training
program is to maximize the likelihood of producing independent clinical research scientists and leaders with
expertise in cutting-edge translational research designs, frameworks, and methodologies that will usher in
breakthroughs in the identification of mental-illness mechanisms, prevention, and treatment. To our knowledge,
this program is one-of-a-kind in the nation and the success of our prior trainees supports its core values and
impact. Following continued success in the previous training period (years 5–9), federal funds are requested to
continue supporting six predoctoral trainees per year, complemented by two institutionally supported trainees,
for up to two years. Training opportunities focus on four basic aims for each trainee: (1) to gain exposure to
foundational concepts, theories, and methodologies, as well as exemplars of both CTS and multiple units of
analysis informed by the RDoC; (2) to apply this integrated framework to research addressing a public-health
issue; (3) to learn to foster collaborative opportunities that stretch the boundaries of research both along the CTS
continuum and across multiple units of analysis; and (4) to develop professionally to continue this line of research
as an independent clinical scientist. Trainees begin their intensive training by identifying a public-health issue on
which to focus their research efforts. These aims are then realized through (a) structured research activities
under the dual mentorship of a primary and a “stretch” mentor (designed to extend the research either along the
CTS continuum or across units of analysis); (b) dual research mentoring of the trainee leading to submission of
a research proposal (e.g., an F31 NRSA application); (c) peer, advanced trainee, and expert guidance and
feedback on their research through a year-long seminar; (d) tailored doctoral qualifying examinations; (e)
coursework and advanced seminars focused on addressing mental-health issues within the CTS and RDoC
frameworks; (f) workshops in professional development, responsible conduct of research, and grant writing; and
(g) colloquia and conferences to offer networking and collaborative opportunities. Trainees work with their dual
mentors to design an individualized program of study in combination with the activities listed above.

Public health relevance
Project Narrative This unique program will provide comprehensive predoctoral research training at the intersection of clinical translational science and the NIMH Research Domain Criteria to accelerate the preparation of trainees to make substantive contributions to the understanding and alleviation of mental-health problems. Six NIH and two institutionally funded psychological and brain science trainees per year will receive structured applied experiences, didactics, seminars, and workshops from dual mentors, with a focus on the building of a cutting- edge clinical translational program of research, grant writing, and professional development for each trainee.